Endothelial Dysfunction and Vascular Inflammation

Introduction and Objective: Septic shock marks the point in a severe infection when cascading responses overwhelm compensatory mechanisms resulting in overt cardiovascular failure. The appearance of vasopressor requiring hypotension substantially increases the risk of death from infection. Up to 75% of septic shock non-survivors die in refractory shock during the first 7-10 days of illness. In refractory septic shock both vascular relaxation and constriction ultimately become impaired, an abnormality analogous to endothelial dysfunction and injury in chronic atherosclerosis. This investigation is exploring the mediators, signal transduction pathways, and underlying mechanisms of endothelial dysfunction and vascular inflammation. Progress: Transfection of monoblastoid U937 cells with human eNOS resulted in a cell line that produces nitric oxide in response to a calcium ionophore, but little or no nitric oxide in the resting state (Blood, 1997). However, after differentiation with phorbol-12-acetate-13-myristate, eNOS expressing cells produced increased amounts of both TNFa and reactive oxygen species by mechanisms that were independent of nitric oxide. Neither Nw-methyl-L-arginine, a NOS inhibitor, nor mutation of the L-arginine binding site of eNOS, rendering it incapable of producing nitric oxide, blocked the ability of eNOS to upregulate TNFa. Conversely, co-transfection with superoxide dismutare or deletion of the NADPH binding site of eNOS completely prevented eNOS from upregulating TNFa production. These results suggest that eNOS can regulate inflammatory responses through both nitric oxide and reactive oxygen species-based signal transduction pathways. Superoxide produced by eNOS was shown to upregulate TNFa via p42/44 MAPK activation. Proposed Course of Work: Experiments are underway to globally characterize the effects of high mobility group protein (HMG-B1), a late endogenous mediator implicated in septic shock mortality, on the transcriptome of primary human endothelial cells. This inflammatory mediator is being combined in a 2 x 2 design with cycloheximide to separate out secondary regulatory events that require protein synthesis from those that do not. Exploration of nitric oxide-triggered signal transduction pathways in a human-mouse hybrid endothelial cell line. Initial studies demonstrate that exogenous nitric oxide inhibits proteosome function and activates p38 MAPK. Developed an in vitro model of endothelial cell dysfunction using a RNA-mediated interference (RNAi) approach in primary cells. Currently constructing plasmids designed to knockdown eNOS expression. Endothelial dysfunction has been associated with reduced eNOS expression or function in a wide variety of models and clinical settings including sepsis and atherosclerosis. Gene knockdown will be followed by phenotypic characterization using Western blot, flow cytometry, and oligonucleotide microarrays in the presence and absence of inflammatory-mediator activation (TNFa, HMG-B1). In parallel experiments, RNAi will be used to knockdown the BMPR2 gene. Loss of BMPR2 function has been linked to primary and secondary pulmonary hypertension, a form of endothelial dysfunction that affects the pulmonary vasculature. At present, it is planned to combine BMPR2 knockdown with eNOS knockdown in a 2 x 2 design followed by phenotypic characterization and expression profiling. Data from this in vitro work will be examined and analyzed in the context of clinical samples from a protocol (in preparation with Michael Solomon, M.D.) enrolling patients with primary pulmonary hypertension.